Diversity supplement to R00AG071838: Well-being as a Protective Factoragainst Cognitive Decline and Dementia

Project Summary
This administrative supplement will provide an 18-month postbaccalaureate research training
and mentorship program for Ms. Payton Rule under the parent project R00AG071838: Well-
being as a Protective Factor against Cognitive Decline and Dementia (PI: Dr. Willlroth). Ms.
Rule received her undergraduate degree in Philosophy-Neuroscience-Psychology at
Washington University in St. Louis in May of 2022 and has been working with Dr. Willroth and
Dr. Patrick Hill as a part-time lab manager since then. Ms. Rule’s ultimate goal is to study well-
being and resilience among people aging with disability/chronic illness. In line with her career
goals to investigate well-being and resilience in people with disabilities, Ms. Rule will examine
well-being as a protective factor that disrupts bidirectional associations between mobility
disability and cognitive decline. The supplement aims will be addressed by examining two
datasets, Rush MAP and MARS, which both address mobility disability utilizing the Rosow-
Breslau scale. Similar to the parent R00, multiple longitudinal structural equation models will be
employed to to examine potential bidirectional associations between mobility disability and
cognitive decline. Furthermore, various types of well-being will be introduced as moderators to
test whether higher levels of certain types of well-being may mitigate the strength of the
association between mobility disability and cognitive decline. This supplement will also address
career training goals for Ms. Rule, including quantitative methods, scientific manuscript and
grant writing, and expertise in cognitive aging and disability studies. The aims of the supplement
address the NIH goals of promoting diversity in scientific research and will strongly enhance Ms.
Rule’s career development within the field.

Public health relevance
Project Narrative The administrative supplement will continue the parent project’s aim of examining associations between different components of well-being (e.g., positive emotion, sense of purpose) and cognitive decline while also examining the role of disabilities with these associations. Given the large number of older adults living with mobility and/or cognitive disability, it is crucial to better understand relationships between these factors in order to build up resilience among the aging population.